ETIOLOGY AND PREVENTION OF SIMIAN ACQUIRED IMMUNE DEFICIENCY SYNDROME

At various primate research centers, several macaque species show an acquired immune deficiency syndrome (simian AIDS, SAIDS) characterized by lymphocytopenia, opportunistic infections,and a fibromatosis tumor (RF). Numerous type D retroviruses (designated SAIDS-D/Washington (SAIDS-D/W) have been isolated from several macaque species by cocultivation of tissues and blood with lymphocyte and monolayer cultures. These isolates morphologically transform certain rodent cell lines. The SAIDS-D/W isolates can be distinguished from all other retroviruses by antigenicity and molecular hybridization, including the related type D viruses isolated from the California and New England Primate Centers, as well as Mason-Pfizer monkey virus (MPMV) and langur monkey type D viruses. Six structural proteins from SAIDS-D/W and MPMV have been purified and sequenced; these include the gag proteins p4, p10, p12, p14, p27 and a phosphoprotein designated pp18 for MPMV and pp20 for SAIDS-D/W. The gag proteins of these two viruses are distinct but share a high degree of amino acid sequence homology. The phosphoproteins differ entirely in amino acid composition and molecular weight. The N-terminal portion of SAIDS-D/W pp20 shows an unexpected homology to a 28 residue segment of the env precursor polyprotien of Rous sarcoma virus. Epidemiological studies on approximately 25% of the Washington colony revealed that 57% of the macaques have antibodies to SAIDS-D and 2% to HTLV-I. Twenty animals with RF have SAIDS-D viral sequences in their tumor tissue and SAIDS-D virus has been isolated from all of these animals. Biologically cloned SAIDS-D virus has been inoculated into 19 macaques; four young animals have developed viremia and RF, and another eight animals have developed high antibody titers to various viral proteins. These antibodies neutralize the SAIDS-D virus but not a macaque type C virus. Various antiviral regimens and vaccination protocols are being assessed in an attempt to prevent this disease.